Utilization of molecular targeted radionuclides to prime immune responses at local and distant metastatic tumor sites

ABSTRACT
Combining local radiation therapy and systemic immunotherapy to produce an abscopal tumor response at a
distant unirradiated site has been the “holy grail” of radioimmunotherapy. Preclinical data has shown that
radiation and systemic immunotherapy can be combined to provide an enhanced response, however translation
into the clinical setting has been much more difficult. These mixed results may partly be explained by
immunosuppressive effects of high tumor burden or distant disease as well as the fact that many cancers are
poorly immunogenic or “cold” with low response rates to immunotherapeutic treatments. Therefore, the aims of
this proposal look to enhance the efficacy of immunotherapy treatments in preclinical models of metastatic
immunologically “cold” tumors that don’t respond to traditional systemic immunotherapy such as immune
checkpoint inhibitors (ICI, e.g. anti-CTLA4, anti-PD1) and most closely resembles our current target patient
population today in whom we are trying to improve outcomes. Therefore, we developed a metastatic model of
immunologically “cold” melanoma with a large established primary tumor, bulky secondary disease sites, and
distant disease sites that resembles the type of disease burden we need to treat in our patients in the clinic. Our
preliminary data shows that to optimize cure rates in this model we require a three-prong approach. First, we
utilize a strong local in situ vaccine regimen (ISV) consisting of external beam radiation therapy (12 Gy x 1) and
intratumoral injection of a tumor specific antibody and IL2. Next to prime distant disease for systemic
immunotherapy treatment we utilize a novel molecular targeted radiotherapy (MTRT) agent, NM600, which is a
diapeutic alkylphosphocholine molecule that has been chelated to 86/90Y. These MTRT agents have previously
been shown to have selective tumor uptake in virtually all mammalian tumor cells tested (including > 70 tumor
lines and in patients across various clinical trials). Lastly, we will utilize systemic ICI to continue a robust adaptive
immune activation response and suppress escape mechanisms. Our preliminary data shows that this
combination treatment is effective in curing local, distant, and metastatic disease in an immunologically “cold”
melanoma model that doesn’t respond ICI alone. For the aims of this study we will: 1) expand on our preliminary
data showing uptake of MTRT to sites of distant disease and calculate tumor dosimetry 2) demonstrate the ability
of MTRT to modulate a tumor microenvironment at both distant and local sites to enhance the efficacy of immune
response, and 3) test the efficacy of this treatment approach in a variety “cold” tumor models such as melanoma
(B78), neuroblastoma (NXS2), head and neck cancer (MOC2), breast cancer (4T1), and a spontaneously arising
transgenic melanoma model. The insights and knowledge gained by this proposal should allow us to provide
valuable justification to translate this treatment to clinical testing in patients and potentially improve outcomes in
patients with any type of metastatic cancer.

Public health relevance
PROJECT NARRATIVE We are developing a new approach, representing a dramatic shift in the treatment of metastatic cancer, utilizing immune responses to recognize and destroy cancer (known as immunotherapy) in combination with low-dose radiation therapy, which substantially improves the anti-tumor potency of the immunotherapy regimens we are creating. We have shown that low-dose radiation, if delivered to all sites of cancer in a mouse, enables our combination immunotherapy approach to destroy tumor throughout the mouse; however, there are great difficulties in delivering conventional radiotherapy to all cancer sites in patients when cancer has spread to many sites. Instead, we are giving molecular targeted radiotherapy that can be injected into a patient’s vein and can go throughout the body to preferentially deliver the radiation to tumors wherever they are located.